SCH: Robotic Caregiver to Comprehend, Assist, Relieve, and Evaluate for Patients with Alzheimer’s Disease (Robotic CARE for AD)

As the number and proportion of people aged 65 or older continue to increase in the United States, the
number of Americans living with dementia is also growing. Among all dementia, Alzheimer’s disease (AD)
and related dementia (ADRD) is the most common cause, accounting for approximately 60%-80% of the
cases. Improving the care of people living with ADRD impacts the lives of not only the patients and their
family but also the caregivers and their family, posing significant challenges to the well-being of the
society. The purpose of this project is to exploit the autonomy and intelligence capability of a humanoid
robot to comprehend, assist, relieve, and evaluate (CARE) patients with AD. The proposed Robotic CARE
system has the capacity to detect the emotion and cognitive state of an AD patient, communicate and
collaborate with the patient to accomplish basic instrumental activities of daily living (IADL) such as meal
preparation, laundry, self-feeding, as well as help caregivers by reducing their levels of burden and stress.
The proposed system could effectively bridge the CARE gap in our society, offering unprecedented
potential for improving the quality of lives of both the patients and their caregivers. It is worth mentioning
that the proposed Robotic CARE system is not to replace the caregivers, but rather to supplement the
caregivers while providing companionship for AD patients since the system will learn to automatically
assess patients’ cognitive state so as to better understand and respond to patients’ need.
The CARE system is expected to advance the state-of-the-art in several related fields with its innovative
and unique integration of cognitive assessment and rehabilitation with robot-assisted care. The proposed
system makes contributions from three perspectives. First, cognitive assessment using instrumental
activities of daily living (IADL) for patient-caregiver interaction will be conducted. Second,
neurophysiological assessment using multimodal integration and unsupervised learning for patient-robot
interaction will be conducted. Third, co-robot assessment using reinforcement learning for
patient-robot-caregiver interaction will be conducted. The proposed team includes expertise from nursing
with specialty in dementia care and gerontology, biomedical engineering with specialty in brain-computer
interface, and computer science with specialty in machine/deep learning.

Public health relevance
Improving the care of AD and related dementias is a national challenge, which demands integrated multidisciplinary approaches. This CARE system may help to improve patients’ independence and, thus, quality of life. It also helps to address the challenge of increasing demand for care and shortage of care resources for AD and related dementias.